West Coast Consortium for Technology and Innovation in Pediatrics

Project Title: West Coast Consortium for Technology & Innovation in Pediatrics
Project Summary
The Southern California Consortium for Technology and Innovation in Pediatrics (CTIP –
www.scctip.com) is a pediatric medical device consortium based at Children's Hospital
Los Angeles (CHLA) and the University of Southern California (USC) established in
2011 and first funded by the FDA in 2013. CTIP promotes commercialization and clinical
use of pediatric medical devices as encouraged by the U.S. Food and Drug
Administration. CTIP facilitates the development of pediatric medical devices by
coordinating resources within the existing translational and commercialization framework
of CHLA and USC and the Southern California community to a stage where they can be
transferred to a commercial partner and brought to market. Over the past year, CTIP has
focused on developing partnerships across the West Coast, evolving into the West
Coast CTIP Network. The new CTIP includes academic and industry partners from every
major metropolitan area in California, Oregon, and Washington. CTIP’s over-arching
goals are: 1) to build upon our network of multi-disciplinary stakeholders across the West
Coast to identify and foster promising pediatric medical device projects; 2) to increase
awareness around the need for novel pediatric medical device development; 3) to
overcome current barriers to commercialization with a particular focus on establishing
academia’s role in alleviating these barriers; and 4) to develop and implement strategies
that will sustain a productive needs-driven pipeline of new pediatric medical devices.
CTIP was established by uniting faculty and administrative leaders from schools,
departments, programs, institutes, and centers at USC and CHLA that are focused on
commercialization, translational and clinical research, pediatric care, and engineering.
This core group is now joined by key leaders representing partner institutions across the
West Coast Network. CTIP engages the business, investment, higher education, and
philanthropic communities in the West Coast in order to provide CTIP portfolio
companies with comprehensive pediatric medical device development services.

Public health relevance
The Southern California Consortium for Technology and Innovation in Pediatrics (CTIP) was first funded by the FDA in 2013, and over the past 5 years has consistently delivered on its mission to advance the development and commercialization of necessary and novel pediatric medical devices. In this new proposal we 1) Highlight our track record of success in supporting medical device innovators, 2) Exhibit our network of resources and services, as well as our comprehensive approach to assessing and supporting innovators, 3) Introduce our evolution into the West Coast CTIP, with partners in every state on the west coast, and 4) explore how our advance clinical informatics team can help lead the way in the generation, collection, and use of real world evidence for pediatric medical devices.